National Xenopus Resource Center

Project Summary – Project Component
The Project Component outlines the applied research of the National Xenopus Resource (NXR). Transgenic
lines are the single largest component of the NXR. These lines are essential for individual labs and their sales
are increasing each year. In recent years, it has been shown that in most mouse transgenic lines there are
genomic alterations in and around the integration sites of transgenes. These changes can influence the
expression of endogenous genes or even cause mutations in these genes. Therefore, it is essential that we
define the integration sites for our transgenic lines. In this Component we outline the steps we will take to identify
the integration sites for five of our transgenic lines.